Defining the neurocircuit activated by the VMH to control energy expenditure.

PROJECT ABSTRACT
While body weight is tightly regulated in healthy individuals, obesity results from failed homeostatic
mechanisms that protect individuals from metabolic disease. Obesity already plagues approximately 100 million
people and costs approximately $200 billion dollars annually in this country. Thus, it is imperative that we find
better ways to treat obesity before this problem gets out of control. The brain contains unexplored potential
avenues for obesity treatment. While it has been clear that neural mechanisms can dramatically shift energy
homeostasis, these mechanisms have been poorly described to this point. Specialized neurons detect changes
in energy status. Because the brain exhausts almost a quarter of all nutrients in the body, it is especially
important for the brain to keep energy levels in a normal range. Therefore, there are undiscovered, or not
completely discovered, built-in systems into the brain that maintain energy homeostasis.
Recent studies have aimed to understand the function of distinct sets of cells in the brain involved in
individual aspects of metabolic function. This has recently been revealed to be the case for a key area of the
brain called the ventromedial hypothalamus. We have published papers that identify a set of cells within this
brain area is essential for hypoglycemic counterregulation, a critical factor for diabetes treatment. These cells
are intermingled in the same area with others that are essential for energy balance by stimulating energy
expenditure. Removing the neuropeptide pituitary adenylate cyclase activating polypeptide centered on the
ventromedial hypothalamus induces obesity. Because there are no direct connections from the ventromedial
hypothalamus with peripheral organ targets, these functions must be controlled through a downstream site to
that responds to pituitary adenylate cyclase activating polypeptide.
In this proposal, we aim to identify both the anatomical and the cellular targets in the regions that
ventromedial hypothalamus neurons project. Our preliminary data indicate that ventromedial hypothalamus
neurons only project to a few sites. These projections particularly overlay with the caudal divisions of the preoptic
area, a region critical to energy expenditure control. We will employ genetic mouse models in conjunction with
AAV-driven gain or loss of function experiments to test the hypothesis that dietary signals that communicate fuel
adequacy to engage the neuropeptide in the ventromedial hypothalamus and action within the preoptic area on
neurons that are inhibitory and contain the receptor for the neuropeptide. We will define the dietary signals that
require the ventromedial hypothalamus neuropeptide and downstream communication by these cells. We will
then determine the downstream regions that requires activation by the neuropeptide receptor and communication
by these cells. Then, we will identify the inhibitory cells within the preoptic area that contain the neuropeptide
receptor and the peripheral actions they engage to support energy balance through energy expenditure.

Public health relevance
PROJECT NARRATIVE This project will identify new mechanisms by which the brain influences energy balance through energy expenditure. We will focus on a ventromedial hypothalamic neuropeptide and the mechanisms that it engages within downstream brain regions. We will determine the signals that necessitate this neuropeptide signal, where neuropeptide action is required, and reveal the cells and mechanisms engaged in peripheral target adipose and muscle tissues.